Zoonotic tick-borne pathogens contribute to acute febrile illness in rural South Africa

PROJECT SUMMARY/ABSTRACT SECTION
More than 60% of infectious diseases in humans are spread from animals, often by an arthropod vector. In recent
years, vector-borne viral, bacterial and parasitic diseases have emerged or re-emerged in many regions causing
global health and economic concerns. The ecology and epidemiology of these diseases are affected by the
interrelations between the pathogen, the host and the environment. Vector-borne infections transmitted from
wildlife reservoir species to domestic animals or humans are thus of major concern. The Mnisi One Health
Platform was established to facilitate research at the cusp of human/livestock/wildlife interface. The Mnisi
community is a rural, impoverished area that is situated in the Mpumalanga Province, South Africa. The
community shares 75% of its boundary with wildlife reserves, including the Kruger National Park, and provides
an environment where there is interaction between humans and domestic and wild animals. The Hans Hoheisen
Wildlife Research Station is a well-equipped laboratory on site enabling researchers to process samples on site.
The community supports research activities and interventions in return for assistance in an array of health related
areas. Using this rich infrastructure, we plan to test the hypothesis that a significant proportion of non-malarial
acute febrile illness (AFI) in the Mnisi community can be attributed to tick-borne zoonoses. Some of our early
findings suggest that zoonoses, particularly tick bite fever, Q fever and human granulocytic anaplasmosis need
to be considered in the investigation of febrile patients presenting for care in Mnisi. In an effort to address this,
we plan to study tick-borne pathogens at the wildlife-livestock-human interface, and to identify potential
aetiological agents of febrile illnesses in this community. Our first goal is to test samples from human patients
who present with non-malarial AFI at the health clinics in the Mnisi community for the presence of zoonotic
pathogens using a metagenomic approach. Next we will analyze the microbiome of ticks to determine which tick-
borne pathogens are circulating in the community. We believe that ticks act as a focal concentrator of pathogens
circulating in the community, and therefore will provide a representative sampling of tick-borne pathogens.
Unknown organisms that are detected in both sample sets will be identified as putative pathogens. We then plan
to examine a range of samples for the presence of the spotted-fever group rickettsiae, C. burnetii, A.
phagocytophilum, Bartonella spp and any other significant putative pathogens identified. The genetic diversity of
the organisms identified will be analyzed. The putative tick vector(s) and reservoir hosts will also be identified.
Based on this, diagnostic tests can be implemented in rural communities ensuring appropriate interventions and
benefiting human health and well-being. This proposal focuses on zoonotic tick-borne diseases in South Africa;
our knowledge base of zoonotic tick-borne pathogens impacting human health in South Africa will be expanded
and our understanding of the challenges faced by rural communities living at the interface will be enhanced. This
will be of value not only for South Africa, but also for other African countries.

Public health relevance
PUBLIC HEALTH RELEVANCE Febrile illnesses remain a major cause of morbidity and mortality in resource-poor countries, and too often, tests are not available to determine the causes, leading to misdiagnosis and inappropriate treatment. Also, the majority of novel human pathogens that have emerged in recent decades have been shown to originate from animal hosts, including HIV, Ebola virus, SARS coronavirus, and the influenza viruses H5N1 and H1N1. Vector-borne infections transmitted from wildlife reservoir species to humans are thus of major concern. A need exists for the active surveillance for potential pathogens in order to predict and combat emerging tick-borne diseases. This project will identify both novel pathogens and pathogens that are expanding their range into the Mnisi area, and in so doing will characterize the pathogens to determine the most appropriate test to use for detection. !